Disseminating and Implementing MedSMA℞T Families in Emergency Departments: A Randomized Control Trial to Assess Effectiveness of an Evidence-Based Gaming Intervention to Reduce Opioid Misuse

Project Summary/Abstract
Adolescents (ages 12-18) are uniquely at risk for prescription opioid misuse for a variety of reasons, including
inadequate knowledge about safety risks, easy access to opioids stored improperly in the home, and limited
family communication about opioid safety in the home. Although adolescents identify parents as useful resources
for opioid safety information, parents report they do not have the comfort or skills to talk to their children about
opioid medication safety. Introducing an intervention at the point of care in emergency departments (EDs) (i.e.,
when an adult is prescribed an opioid prescription) is an accessible, low-cost, way to provide opioid education
and facilitate communication about opioid medication safety among youth and their families. Although
adolescents represent a public health priority population, no intervention has attempted to improve adolescent
and parent knowledge, attitudes, and behaviors about opioid safety to prevent adolescent opioid misuse in EDs.
Our transdisciplinary team, with experts in community engagement, dissemination and implementation science,
emergency medicine and pediatrics, family medicine and community health, addiction medicine and substance
use, adolescent and digital health, game design, biostatistics, health economics, and mixed-methods research,
will collaborate with a health system: UW Health. The collaboration will lead to the adaptation and evaluation of
a digital health intervention (MedSMA℞T Mobile) in health system EDs, to improve medication safety among
adolescents and their parents, thus reducing prescription opioid misuse. The MedSMA℞T Mobile intervention
incorporates the evidence-based serious game – MedSMA℞T: Adventures in PharmaCity – and a personalized
family medication safety plan to promote opioid safety communication between youth and parents.
We will use the Exploration, Preparation, Implementation, Sustainment (EPIS) framework to ensure continual
optimization of MedSMA℞T Mobile in ED settings. Three aims support the goal of reducing opioid misuse for
adolescents and their parents. First, qualitative evaluation of adolescents, parents, and ED staff stakeholders
will generate feedback used to iteratively adapt MedSMA℞T Mobile for its maximal availability in ED settings,
while also informing an Implementation Package for more widespread ED adoption. Second, a randomized
controlled trial will be used to evaluate effectiveness of MedSMA℞T Mobile to improve adolescent/parent opioid
misuse knowledge, attitudes, and behaviors over 9 months. Finally, MedSMA℞T Mobile will be made available
in more EDs, and interviews and a survey will be used to evaluate ED staff perceptions of sustainability and
organizational preparedness for sustainability, while exploring health cost impact of increased opioid safety.
Leadership from the health systems, as well as their front-line ED staff, are committed to promoting awareness
of this innovative intervention for families receiving an opioid prescription. This is the first preventative
intervention designed in direct response to an unmet critical need identified by the AHRQ Call for Proposals (PA-
18-793) to design, implement, disseminate and spread, and evaluate interventions to improve patient safety.

Public health relevance
Project Narrative Teens are at risk for prescription opioid misuse due to easy access to opioids in the home, seeing their friends and parents using opioids incorrectly, not talking to their parents about opioid safety, and lack of educational materials to prevent misuse. A game-based educational tool (MedSMA℞T Mobile) exists that helps teens and parents communicate about opioid medication safety, and this project will make this tool more available in emergency departments (EDs) in Wisconsin and northern Illinois – by (1) changing MedSMA℞T Mobile to fit the needs of individual EDs and their patients, (2) testing whether the MedSMA℞T Mobile tool improves teen/parent opioid misuse knowledge, attitudes, and behaviors, and (3) making the MedSMA℞T Mobile educational tool available in more EDs and getting staff feedback about whether EDs are able to continue to offer it to their patients, while also showing some financial benefits to patient healthcare. This new evidence-based educational game will strengthen families’ knowledge of opioid medication safety risks while also helping them create a personalized medication safety plan, which can reduce teen opioid misuse.